Telehealth Adaptation of Group and Family-Based Cognitive Behavioral Therapy for Youth at Risk for Psychosis

PROJECT SUMMARY/ ABSTRACT
Psychosis typically emerges in late adolescence or early adulthood, which is a vital stage in social and
cognitive development, and can therefore have a profoundly adverse impact on an individual’s long-term
functioning. The onset of psychosis is preceded by a clinical high risk (CHR) phase characterized by
attenuated psychotic symptoms and functional decline. CHR programs have enormous potential to reduce the
long-term severity of the illness, and the suffering and cost associated with it. Youth at CHR also typically have
environmental and individual-level barriers to accessing and engaging in services, including stigma, a dearth of
trained providers, clinic location and transportation issues, suspiciousness, and a tendency to socially isolate.
Reducing some of these barriers via telehealth interventions may improve treatment accessibility and
engagement, thereby improving clinical outcomes. There is a substantial need to evaluate the feasibility of
different CHR interventions to determine which may be most promising and for whom. There is also a
significant need to systematically investigate remote delivery methods as a way of increasing access to critical
services for CHR. We have established a comprehensive Group and Family-Based Cognitive Behavioral
Therapy (GF-CBT) program for youth at CHR. GF-CBT aims to facilitate psychosocial recovery, decrease
symptoms, and prevent or delay transition to psychosis in youth at CHR. GF-CBT is grounded in sociocultural
ecological systems theory, psychosocial resilience models, and research on information processing in
delusions. GF-CBT has been implemented as part of SAMHSA funded CHR services in New York, Missouri,
and Delaware and has been adapted for telehealth delivery (GF-CBT-TH). This study will evaluate the
feasibility and acceptability of GF-CBT-TH and gather data on the preliminary efficacy of GF-CBT-TH
compared to individual CBT for CHR delivered via telehealth (I-CBT-TH). Subjects between the ages of 14 and
25 who meet CHR criteria on the SIPS (n=60) and their families will be randomly assigned to receive GF-CBT-
TH or I-CBT-TH for a period of 15 weeks. Data will be collected at baseline, post-treatment, and 3-month
follow-up. Feasibility of GF-CBT-TH will be measured by recruitment rate, session attendance, dropout rate,
and subjects’ satisfaction with the interventions. The following intervention targets will be assessed in both
groups: cognitive biases, social connectedness, family emotional climate, and family members’ proficiency in CBT
and communication skills at post-treatment and follow-up. The GF-CBT-TH and I-CBT-TH groups will be
compared across the following domains: psychosocial functioning, symptom severity, rates of remission from
CHR, and rates of transition to psychosis. We will also explore whether patient treatment preference (for GF-
CBT-TH vs. I-CBT-TH), family emotional climate and sociodemographic factors will differentially moderate
treatment outcomes. In depth qualitative interviews will be conducted with patients, families, and clinicians to
inform dissemination of GF-CBT-TH and make adaptations to the implementation manuals as needed.

Public health relevance
PROJECT NARRATIVE The knowledge gathered from this project is of significant public health relevance as it has potential to advance treatment for youth at clinical high risk for psychosis (CHR) by evaluating the utility of Group and Family-Based Cognitive Behavioral Therapy for youth at CHR and examining whether adding group and family modalities may be more effective in improving psychosocial functioning compared to individual CBT. We will use telehealth delivery to address challenges that youth at CHR may have accessing treatment, including transportation to local clinics, stigma, stress sensitivity, suspiciousness, and emerging negative symptoms. Telehealth adaptations have the potential to make interventions accessible to a larger number of youth and families, to connect them to social support networks of others with similar experiences across geographically disparate locations, to alleviate their suffering, to reduce psychiatric disability, and to decrease economic losses to society.